Examining Susceptibility and Resistance Phenotypes to Enhance Understanding of the Genetic Basis of Major Coronary Artery Disease in Type 1 Diabetes

ABSTRACT
People with type 1 diabetes (T1D) are at dramatically increased risk of developing coronary artery disease
(CAD), but the reasons for this excess risk compared to the background population are not fully understood.
There is a critical need to identify people at risk of major CAD events early in their T1D natural history and to
develop new therapeutic interventions to reduce CAD risk and burden. While prior studies have examined
associations between genetic variants and CAD in T1D, a lack of strong candidate genes remains. This lack is
at least partially due to the fact that case-control designs using low-precision phenotypes to maximize sample
size and which disregard within-phenotype heterogeneity have been the most common approach to studying
the genetic basis of vascular complications in T1D to date. Likewise, while it is well established that
inflammatory and immune response biomarkers are associated with CAD risk in general and that levels of
these biomarkers are elevated in T1D, the association between such markers and CAD has not been
comprehensively studied in T1D. Inflammatory and immune response biomarkers are intermediate phenotypes
that hold potential to help uncover novel pathways to CAD in T1D and may be promising treatment targets.
Thus, our hypotheses are that unidentified genetic variants associated with CAD susceptibility or resistance
exist and that networks of inflammatory and immune response biomarkers are associated with CAD and may
mediate inflammatory/immune response gene-CAD associations. Our approach will be to first refine the CAD
phenotype definition to one that better reflects the genetic etiology of CAD susceptibility and resistance in T1D.
Specifically, studying highly specific “discordant” risk factor-CAD phenotype subgroups may help uncover
novel pathways to CAD development in T1D. Our approach will increase precision of both genetic sequencing
(by using whole genome sequencing) and CAD phenotype definitions. We will also measure a comprehensive
proteomic panel of 92 targeted biomarkers and derive networks of related markers to assess their associations
with CAD and the degree to which those networks mediate associations between CAD and genes involved in
inflammation/immune response. We will utilize data and specimens from the Epidemiology of Diabetes
Complications (EDC) study, a well-characterized T1D cohort with >30 years of follow-up and deep
phenotyping, allowing us to comprehensively examine many intermediate phenotypes (i.e., traditional risk
factors and novel biomarkers) in gene-to-CAD pathways. Furthermore, we will replicate the findings from this
discovery analyses in external cohorts. With this approach we expect to uncover evidence of novel pathways
that account for a proportion of unexplained CAD risk in T1D and point to new intervention targets.

Public health relevance
PROJECT NARRATIVE The elevated risk of coronary artery disease (CAD) in type 1 diabetes remains largely unexplained by established risk factors. We aim to identify new pathways to CAD in type 1 diabetes through studying genetic variants and novel inflammatory and immune response biomarkers in subgroups of people who are particularly susceptible and resistant to CAD.